Vestibular dysfunction and the development of therapies for Usher syndrome

Project Summary
Collectively, rare diseases affect ~350 million people in the world, and most of them lack specific treatments
resulting in a tremendous unmet medical need. Understanding the underlying genetic and molecular
mechanisms and developing therapies for rare diseases are essential for our efforts to address this urgent
need. The present application focuses on understanding and treating Usher syndrome (Usher), a rare disease
characterized by multisensory loss (hearing, vision, and balance) that creates a major communication and
mobility burden affecting all aspects of life. Currently, there are no treatments to prevent or slow the
progression of Usher. To fill these important gaps, we propose three aims in this collaborative project to
determine the progression of vestibular dysfunction over time in the knock-in mouse model for the most
common type 1 Usher mutation in the Acadian populations of Louisiana and Canada (USH1C c.216G>A) (Aim
1) and in a cohort of pediatric, young adult, and adult USH1C patients (Aim 3), and to test the therapeutic
efficacies of antisense and gene replacement therapies when delivered at different stages of disease
progression in the USH1C mice (Aim 2). These aims are driven by the central hypothesis that USH1C-related
vestibular dysfunction progresses over time and is end-organ specific, which is supported by our strong
preliminary studies that show age-dependent declines of the vestibulo-ocular reflexes, and progressive
saccular hair cell degeneration in USH1C mice. In Aim 1, we will employ a combination of molecular, structural,
single vestibular afferent neurophysiology, and behavioral biomarkers to define the progression of vestibular
dysfunction in USH1C mice over a 1-year time course. In Aim 2, we will continue studies to restoring vestibular
function in neonatal USH1C mice using the antisense and gene replacement therapies and further test their
effectiveness when delivered at various stages of disease progression. In parallel, in Aim 3, we will define the
natural history of vestibular dysfunction in a cohort of 50 USH1C patients by testing their vestibular function at
baseline and 6 months later. These results will fill the important gaps in understanding and treating Usher
disease and allow us to define the clinical outcome measures for future clinical trials. Results from this
collaborative project will identify lead clinical drug candidates, an optimal treatment regimen for restoring
vestibular function in USH1C mice, and define measurable clinical outcomes to guide a first-in-human study of
a treatment for vestibular dysfunction in USH1C.

Public health relevance
Project Narrative There are no treatments to prevent or slow progression of disease in patients with Usher syndrome, the leading cause of combined deafness, imbalance, and retinitis pigmentosa. Studies proposed in this application will use multidisplinary approaches to define the progression of vestibular dysfunction in an Usher syndrome type 1C mouse model and in patients, and continue to assess the efficacy of two novel treatments (antisense and gene replacement) that restore balance in the mouse model. Results from this project will provide the foundation for translation of the treatments in the mouse into clinical trials in patients with Usher syndrome.